Administrative Core

The Administrative Core (AC) for WV-INBRE will be responsible for (1) overseeing the growth and development of the biomedical research network, (2) providing biomedical research opportunities, mentoring and training for network faculty and students, and (3) providing day-to-day logistical support to the WV-INBRE network and the External Advisory Committee (EAC). The AC will be composed of the Principal Investigator, the Program Coordinator, the Data Science Core Director, the Sequencing, Molecular and Related Technologies (SMART) Core Director, Summer Research Program Director, Evaluation Coordinator, Mentoring Coordinator, the Faculty Research Development Program Coordinator, and the Tracking Coordinator. The AC will work with the Steering Committee to ensure that WV-INBRE adheres to its mission in building research capacity in network institutions and that network institutions fulfill their commitments to their faculty and students. The AC will work with the Executive Committee to develop strategies for interacting with the EAC and help oversee the development of workshops, webinars, etc., review progress of the major PUI research projects, and work with the Evaluation Coordinator to determine the impact of WVINBRE on the development of the primarily undergraduate institutions (PUIs) and Project Investigators. The EAC will be composed of five members, who will attend all EC meetings and provide evaluation, guidance and assistance in project review and selection. Members of the AC will direct the Data Science and SMART Cores and Developmental Research Project Program. The Summer Research Program Director will oversee the summer research program to provide summer research opportunities to PUI students and faculty. The Evaluation Coordinator will coordinate all evaluations (internal and external; formative and summative) of the WV-INBRE program. The Mentoring Coordinator will oversee mentoring of network investigators and help match PUI researchers with appropriate mentors. The Faculty Research Development Coordinator will oversee the Faculty Research Development Program, which provides pilot funding, travel funds and equipment grants to the PUI investigators. The Tracking Coordinator will coordinate tracking of the students who participate in WV-INBRE sponsored research projects.

Public health relevance
The Administrative Core (AC) of WV-INBRE is a highly interactive Core for administering the day-to-day operations of the network, developing research network components and providing support for the research network. Through the interactions of the Steering and Executive Committees working with WV-INBRE leadership and input from the External Advisory Committee, the AC will oversee and grow biomedical research infrastructure and capacity across West Virginia.